Support Access to Biomedical and Health Information Core

2. Support Access to Biomedical and Health Information Core Project Summary/Abstract Resource sharing remains a key role for the RML. A resource sharing survey conducted by the National Library of Medicine in 2013 showed that many libraries continue to find DOCLINE to be a vital service in meeting the needs of their users. Although worldwide free access to PubMed has greatly simplified the process for health professionals and others to locate scholarly articles, quite often the full-text of the document is not freely available, and must be obtained through resource sharing channels provided by health sciences libraries. Additionally, some contingents of health professionals, notably public health workers and community health workers, may not have ready access to health sciences libraries, and may inquire from the RML where to obtain document delivery services. The establishment of a NN/LM National DOCLINE Coordinating Office (NDCO) will centralize this function, but there will still be a need for individual RMLs to work with health professionals, Network members, and others seeking advice and consultation regarding document delivery through the Loansome Doc, LinkOut, and Outside Tool services. During the current RML contract, we began working with our Network members on e-science activities, and we were the key sponsor for an E-Science Day: An Opportunity for Education and Networking, held in December, 2011, at the University of California at Davis. For the upcoming Cooperative Agreement, we will greatly expand efforts to promote “big data” through the numerous strategies we have developed to provide training and other resources to support data management activities in the Region.